Surgical Scientist Training Grant in Health Services and Translational Research

? DESCRIPTION (provided by applicant): The goal of this T32 application is to support the continued training of surgical residents to become physician-scientists in Health Services and Translational Research. In our well-funded laboratories, the translational research training of surgical scientists will focus on the fields of trauma, burn, wound healing, and regenerative medicine while training will be initiated in the area of health services research in order to educate surgeons in the critical discipline of clinical outcomes investigation to promote evidenced-based medicine. The former emphasizes translating scientific discoveries from the research bench to the patient's bedside, whereas the latter centers on determining the efficacy of therapeutic interventions to improve clinical outcomes. The purpose of the health services research portion of the training grant is for young surgeons to integrate clinical experience with training in program development and research methods. The curriculum is designed to encourage the participants of the program to become future academic surgical investigators who will apply this training to find solutions to the many challenges posed by the U.S. healthcare system. The purpose of the translational scientific portion of the training grant is to provide formal instruction on laboratory research project design and sound research methods of hypothesis-driven investigation to push the boundaries of surgical innovation. The program will foster a cadre of well-prepared surgical scientists to ease their transition into academics. Future academic surgical investigators will benefit from greater knowledge in both important areas as they will be in the unique position to initiate research that bridges clinical and basic experimentation while also evaluating the effectiveness of their treatments. Our past trainees have successfully launched careers in academics and received PhDs using our T-32 grant training as a career defining experience. Through this newly structured organization in our next iteration of this training grant, this novel program is particularly well suited toward training th academic surgeons of the 21st century.

Public health relevance
PUBLIC HEALTH RELEVANCE: For American surgical scientists to develop new therapies to treat patients with congenital and acquired wounds and deformities, and to determine the efficacy of those treatments, there is a fundamental need to train surgical investigators in these critical areas of medical care. This training grant brings together a successful and expert group of dedicated research investigators who will combine their efforts at a renowned university to train outstanding and promising surgical residents to develop new treatments to enhance healing and to determine the success of the surgical care that is delivered.